Interrogating mechanisms of limb regeneration using a viral toolbox for molecular gain- and loss-of-function

Project Summary
Incomplete healing and limb loss impact millions of Americans each year. However, animals such as the
Mexican axolotl salamander (Ambystoma mexicanum) have an exceptional ability to regenerate complex
organs and tissues, including full limbs. Understanding the molecular mechanisms that make regeneration
possible in the axolotl has the potential to advance therapies for improved human healing and tissue
regeneration. An integral component of regeneration is the potential for contributing cells to revert back to a
developmental-like state in a process called dedifferentiation. Despite its crucial role in limb regeneration, we
know little about the molecular underpinnings of regenerative dedifferentiation. A key limitation to testing
potential regulators of cellular dedifferentiation is a lack of tools that allow gain- or loss-of-function in complex,
post-developmental limb tissue. The work outlined in this application leverages expertise in creating and
applying molecular tools in the axolotl to overcome these challenges by i) validating new viral gene delivery
methods in the axolotl limb and ii) combining viral delivery with novel transgenic strategies for gain-of-function,
CRISPR/Cas-mediated loss-of-function, and cell type-specific nuclei isolation. Using these tools, we will test
the role of a candidate transcriptional regulator in driving dedifferentiation and successful limb regrowth. The
outcome of this work will not only establish new tools to elucidate mechanisms of regenerative
dedifferentiation but will also provide a framework for systematic investigation of regulators of limb
regeneration.

Public health relevance
Project Narrative Although a molecular understanding of salamander limb regeneration has the potential to improve wound repair and regeneration in humans, it has been challenging to perturb gene function in complex, regenerating tissue. The goal of this proposal is to overcome these challenges by combining new viral gene delivery methods with advanced transgenic strategies to induce and assess gene gain- and loss-of-function in limb tissue. Using these tools, we will investigate how transcriptional regulators are able to induce dedifferentiation and maintain regenerative progenitors though the process of limb regrowth.